Evaluating Group-Based Psychological Treatments over Home Video Teleconference for Older Veterans with Chronic Pain

Background: Chronic pain is a critical healthcare challenge for VA, and older Veterans are affected worst. VA
guidelines emphasize psychological treatments as first-line for chronic pain. Yet available psychological
options in VA, including Cognitive-Behavioral Therapy for Chronic Pain (CBT-CP) and Mindfulness Meditation
(MM), produce only modest and time-limited benefits on average and are thus underutilized. To increase
effectiveness and uptake, VHA experts have recommended (1) testing treatments with potentially larger and
more durable benefits, such as [MM that is tailored for chronic pain] and Emotional Awareness and Expression
Therapy (EAET), a unique approach that addresses emotional and relational processes not directly addressed
by CBT-CP or MM; (2) testing group and video telehealth delivered treatments to improve access; (3)
identifying mechanisms of response so that future treatments can target the most powerful mechanisms; and
(4) determining moderators of response to promote treatment matching. A large-scale trial directly comparing
telehealth-presented group EAET, CBT-CP, and MM tailored for chronic pain among older Veterans can
address all these recommendations. Significance: The proposed randomized clinical trial directly compares
EAET, CBT-CP, and MM, each delivered in groups over video telehealth, an important format to promote
access and scalability. In performing lagged analyses of mechanisms, the trial will also generate
comprehensive results on how psychological pain treatments work, including whether EAET, CBT-CP, and MM
work through unique mechanisms based on their respective conceptual models or via shared mechanisms. In
evaluating important demographic variables and other moderators that are mechanistically linked to each
treatment, we will also learn how to optimize benefits and maximize limited resources by selecting the most
appropriate Veterans for each treatment. Innovation & Impact: The trial focuses on older Veterans, an
important but understudied group of chronic pain patients. In addition, the trial's direct effectiveness
comparison of multiple active interventions to each other is quite rare but allows for sophisticated analyses of
mechanisms and moderators. Indeed, the trial uses innovative lagged analyses of mechanisms collected at
multiple time points, whereas most other studies only evaluate whether pre-post changes of mechanisms
correlate with pre-post changes in outcomes. Finally, the study aims to be performed entirely remotely to
increase the impact of findings. Overall, results are expected to impact clinical practice and guidelines within
VA. Specific Aims: Test whether there are differences in outcomes among the three treatments, whether
EAET is superior to CBT-CP and MM, and whether MM is superior to CBT-CP. Test whether potentially unique
mechanisms precede and predict improvements in those assigned to the relevant treatment and potential
shared mechanisms precede changes in outcomes across individuals in all three treatments. Test whether
psychological characteristics that are mechanistically linked to each treatment moderate treatment response,
and explore demographic moderators. Methodology: In a 2-site (VA Greater Los Angeles and VA
Connecticut), 3-arm randomized clinical trial, women (at least 20%) and men multiracial/multiethnic Veterans
age 60-95 years with chronic musculoskeletal pain (n = [216]) are randomized to EAET, CBT-CP, or MM. All
interventions are delivered via video telehealth to Veterans' homes as one 60-minute individual session and
eight 90-minute sessions in groups of 6. Veterans complete self-report questionnaires remotely at baseline,
mid-treatment, post-treatment, and 6-month follow-up. Next Steps/Implementation: The project addresses
the HSR&D priority areas of pain management, aging, and telehealth and is supported by the VA Office of
Mental Health and Suicide Prevention, the VA Office of Patient Centered Care & Cultural Transformation, and
local COINs and Mental Health Services. Following the trial, resources on treatments, findings, and lessons
learned will be sent to our partners, VHA clinicians and researchers, Veterans, and the scientific community.

Public health relevance
[Chronic pain is a serious healthcare challenge for older Veterans. VA guidelines recommend psychological treatments for chronic pain, but available options, such as Cognitive-Behavioral Therapy for Chronic Pain (CBT-CP) and Mindfulness Meditation (MM), produce only modest benefits on average, so many Veterans choose not to use them. The proposed project will compare CBT-CP to an enhanced MM tailored for Veterans with chronic pain and to Emotional Awareness and Expression Therapy, a potentially more effective treatment that addresses emotional and interpersonal drivers of chronic pain (e.g., trauma) that are common in Veterans but not directly addressed by CBT-CP or MM.] All three treatments will be delivered in groups over video telehealth to improve access. In addition, the project will assess which Veterans are most likely to respond to each treatment and how each treatment works. The goals are to determine the best treatment on average, the best treatment for each Veteran, and how to improve future treatments to help more Veterans in a big way.